Michigan Center on Lifestage Environmental Exposures and Disease (M-LEEaD)

SUMMARY/ABSTRACT (Administrative Core)
The Michigan Center on Lifestage Environmental Exposures and Disease (M-LEEaD) mission has two overarching goals: to accelerate research that defines and explains impacts of environmental exposures during vulnerable stages of life, and to promote translation of these findings to improve clinical and public health interventions for the mitigation of human disease. We implement our mission through integrated research, training, and community engagement overseen by the Administrative Core. The Core is led by Center Director Dolinoy with assistance from Deputy Director Meeker. This Core is the administrative unit for the Pilot Project Program (led by Meeker), Career Development Program (led by Associate Director Omenn), and Translational Research Program (led by Associate Director Padmanabhan). Research Teams are elements of the Translational Research Program with team leaders included as members of the Administrative Core. The teams embrace goals set forth in the NIEHS Translational Research Framework to enhance our Center’s translation of basic research into practical applications for patients and communities and serve as a mechanism for members to explore collaborations and coordinate funding opportunity responses. Inclusion of leadership of the Pilot Project, Career Development, and Translational Research programs in the core addresses the Center objective that these programs operate in an integrative manner. Additionally, the leader of the Community Engagement Core (CEC) is a member of the Core, and the citizen co-chair of the CEC Stakeholder Advisory Board is a member of the Core’s Internal Advisory Committee. Core faculty are assisted by an administrative assistant, web designer, and evaluator. The Core is responsible for organizing MLEEaD activities such as meetings, retreats, seminars, and focus groups, and maintaining records of reports, minutes, and evaluation results from such events. In addition, the Core provides fiduciary oversight of the budgets. The Core obtains and considers input on emerging theories, paradigms, and technologies in environmental health sciences and biomedicine at multiple levels, from Research Team reports to director meetings to Internal and External Advisory committees. The Core ensures that activities encourage innovative research for all members, but especially for early-stage investigators, and foster community engagement via multi-directional dialogue among M-LEEaD scientists, community members, and regulatory stakeholders. The Core coordinates responses to urgent environmental concerns, including interactions with other core centers, NIEHS, and relevant organizations. Finally, the Core is responsible for evaluation of the efficacy of M-LEEaD programs, cores, and activities, taking corrective action as warranted. Through this leadership, the Administrative Core ensures a high standard of activities for the translation of basic research findings into practical applications to advance a comprehensive and integrated environmental health paradigm.